A Novel Fiber Embedded Hydrogel Temporomandibular Joint Disc Replacement

Project Summary
Temporomandibular joint (TMJ) disorders inflict approximately 5% to 12% of the population. For advanced
disorders of the articular TMJ disc, which typically do not respond to conservative treatments, disc resection is
the most common surgical intervention. However, the TMJ disc plays a critical role in distributing mechanical
stresses and preventing wear to the articular surfaces of the joint. Thus, removing the disc can further disrupt
joint homeostasis, driving degeneration and the development of osteoarthritis, which can lead to highly invasive
and challenging surgical interventions such as reconstructions and total joint replacement. Prior attempts at
replacing the disc with alloplastic implants have led to deleterious pathological changes related to wear
debris, implant fragmentation, and adverse inflammatory responses. Therefore, it is crucial to consider wear,
mechanical strength, and biocompatibility of disc replacement materials in the context of long-term cyclic
loading in the TMJ. Overall, there is a critical need for disc replacements that can restore the homeostasis of
the joint when disc resection is required prior to the development of severe joint degeneration. Accordingly, the
objective of this proposal is to create an artificial TMJ disc that replaces the mechanical function of the native
disc and prevents subsequent degeneration of the joint. Towards this goal, the proposed research will
characterize the mechanical loading environment of the TMJ in order to determine the mechanical criteria of
a TMJ disc replacement needed to minimize internal stresses in the joint (Specific Aim 1). Further, non-
resorbable fiber-embedded hydrogel materials will be fabricated, optimized to exhibit biomimetic properties,
and developed into a patient-specific synthetic TMJ disc implant. Rigorous mechanical evaluations will
determine material durability and suitability as a TMJ disc replacement (Specific Aim 2). Finally, a large animal
study will be utilized to evaluate the safety and efficacy of the developed TMJ disc replacement (Specific Aim
3). Successful completion of the proposed work would represent a paradigm shift in the treatment of TMJ disc
disorders that can mitigate further joint degeneration and prevent more invasive and complicated surgeries.

Public health relevance
Project Narrative Severe disorders of the temporomandibular joint (TMJ) disc often require removal of the disc; however, these surgical interventions have exhibited a failure rate of approximately 25%. The TMJ disc plays an important role in maintaining joint health; therefore, our group has developed a synthetic TMJ disc replacement approach consisting of a biocompatible fiber–embedded hydrogel that we can tune to mimic the mechanical properties of the native TMJ disc. We hypothesize that this disc replacement can restore long-term homeostasis to the joint, alleviating pain and preventing the need for more invasive and challenging surgical treatments such as total joint replacement.